CENTER FOR AMERICAN INDIAN AND ALASKA NATIVE DIABETES TRANSLATION RESEARCH

Center Overview: Project Summary American Indians and Alaska Natives (AI/ANs) are at substantial risk of diabetes. They exhibit rates of diabetes often greater than other citizens; they suffer serious, debilitating complications thereof; a disproportionate share of their scarce health care resources are consumed by a small percentage of patients with diabetes. A growing body of knowledge about evidence-based policies, programs and practices promises to redress these disparities. The Center for American Indian and Alaska Native Diabetes Translation Research: 1) Provides an administrative structure that promotes diabetes-related translational research capacity. Its Pilot and Feasibility Program supports small-scale, innovative projects; the Enrichment program offers related training, technical assistance, and consultation to investigators and key stakeholders; 2) Sustains and expands a Research Base of funded faculty whose research either directly targets diabetes prevention and treatment or is translational in nature with clear potential for application to diabetes translational research; 3) Supports a Translational Research Core that offers resources in community engagement, cultural adaptation of intervention, health literacy, health technologies, dissemination and implementation science, and sustainability to advance a multidisciplinary, culturally grounded, problem-oriented translational research program of major scientific and programmatic importance; 4) Serves as a National Resource Core for other investigators pursuing diabetes translational research with AI/AN communities; and 5) Establishes a Health Disparities Population Core that promotes the dissemination of lessons learned in this Center's areas of expertise to other rural, underserved, and under-represent racial/ethnic populations.

Public health relevance
Center Overview: Project Narrative American Indians and Alaska Natives (AI/ANs) exhibit high rates of diabetes and serious, debilitating comorbidities, the treatment of which consumes a large share of increasingly scarce health care resources. This Center promotes research and builds capacity that promises to redress these disparities.